Crosstalk between innate-immunity human microglia and adaptive-immunity Tregs in Alzheimer's disease

Title: Crosstalk between innate-immunity human microglia and adaptive-immunity Tregs in Alzheimer’s
disease (RFA-AG-22-017)
Project Summary
This application is in response to RFA-AG-22-017, looking at crosstalk between innate and acquired
immunity in Alzheimer’s disease (AD). AD affects ~5% of people over age 65, and its prevalence is
increasing. Neuroinflammation has been described in neurodegenerative disorders, and particularly in AD.
Microglial cells, the resident macrophages of the central nervous system (CNS), respond to different pro-
inflammatory stimuli by releasing glutamate, as well as pro-inflammatory cytokines and chemokines. Glutamate
release from astrocytes and microglia has also been observed after exposure to Aβ and to αSyn, proteins that
are misfolded in AD. T lymphocytes, express several NMDA-type glutamate receptors (NMDARs), and we
have also detected their expression in Tregs, whose activity can reportedly ameliorate neurodegenerative
disorders. Using patch-clamp recording, our Preliminary Studies show for the first time the presence of
functional NMDAR-operated ion channels on human Tregs. Glutamate is known to affect T cell migration and
activation; however, the effect of glutamate on Treg migration/activation has not been reported, and,
specifically, it is not known how this might impact neurons in AD brain.
We hypothesize that glutamate exposure of Tregs will limit their release of anti-inflammatory and
neuroprotective factors, thus contributing to neuronal synaptic damage and cell loss. This crosstalk between
the innate and acquired immune system may represent a significant contributor to the pathogenesis of AD. We
have recently developed a protocol for generating human iPSC-derived microglia (hiMG) following a yolk sac
differentiation method (brain microglia originate from the yolk sac and not from the bone marrow). We will test
our hypothesis using a platform of hiPSC-derived microglia (hiMG), human Tregs (isolated from normal blood
donors), and hiPSC-derived cerebrocortical neurons (hiN) bearing AD mutations (vs. their isogenic/gene-
corrected controls). Using this platform, we show in our Preliminary Studies that hiMG release glutamate
following activation with oligomeric Aβ and αSyn. We will systematically investigate the mechanism of the
activation of Tregs by glutamate released by hiMG, and the effect of this cellular crosstalk on neuronal
function. We will evaluate neuronal synaptic integrity and function as well as neuronal survival.
The knowledge gained from this study will shed light on the effect of glutamate on neuroinflammation in a
human context, and will provide insight into the effect of crosstalk between human microglial and Tregs in
stimulating Treg activation. Thus, the work may aid in the development of future novel therapeutic interventions
based on human microglial and Treg function and interaction.

Public health relevance
NARRATIVE Alzheimer’s disease (AD) is the most common neurodegenerative disorder and currently has no disease- modifying treatment. Regulatory T cells (Tregs) express several NMDA-type glutamate receptors (NMDARs), including GluN1, GluN2A, GluN3A and GluN3B; however, the effect of glutamate on Tregs migration/activation has not been reported, and, specifically, it is not known how this might impact neurons in Alzheimer’s disease (AD) brain. In this study we will utilize human cells: Tregs isolated from blood and hiPSC-derived microglia and neurons to study the interaction between these cells and understand how glutamate regulates the crosstalk between microglia and Tregs in Alzheimer’s disease.